Bioinformatics Core Facility

For this past year, the NINDS Bioinformatics Core fulfilled 441 analysis-related requests asked us by 75 different research staff. For the requests fulfilled, they included 27 different categorical types: Ad-hoc Omics Related, ChIP-Seq Analysis Related, Classical Sequence Analysis Related, Long Read Analysis Related, Mass-Spec Analysis Related, Meta Analysis Related, Metabolite Analysis Related, miRNA Microarray Analysis Related, miRNA-Seq Analysis Related, Molecular Dynamic Modeling Related, mRNA Microarray Analysis Related, Nanostring Analysis Related, Pathogen-Seq Analysis Related, Population Genetics Analysis Related, Presentation :: Publication Related, Protein Microarray Analysis Related, Protein Sequence Analysis Related, Protein Structure Analysis Related, RNA-Seq Analysis Related, sc/nRNA-Seq Analysis Related, sgRNA-Seq Analysis Related, Somamer Analysis Related, Survival Analysis Related, Talent Recruitment Acquisition Related, Training :: Mentorship Related, Transposable-Seq Analysis Related, Variant Analysis Related.

The NINDS Bioinformatics Core also continued to work on and support 9 different applications to support clinical-related needs and ongoing research: (i) OSTRICH, a non-public stand alone application designed for the collection and secure storage of patient data when there is no network connectivity, (ii) eStroke2, a non-public web-based application designed to capture stroke patient data collected during the hospital admission process, (iii) eStroke2-GO, a non-public mobile application designed to capture stroke patient data collected during the hospital admission process, (iv) EDGE, a public web-based application to assist healthcare professionals determine what American Heart Association guidelines should be considered regarding endovascular therapy, (v) Core Tool, a non-public web-based application designed to perform automated image "core" lesion segmentation to better assess severity of stroke patients upon their presentation to the hospital, (vi) eSIRIUS, a non-public application for animal inventory tracking, (vii) EncoMPASS, a public web-based application designed to enable a user to perform an integral membrane protein query and related analysis, (viii) StemcellDB, a public web-based application designed to enable a user to explore the data collected from 21 hESC lines that define the NIH Human Pluripotent Stem Cell Registry, (ix) SeqSeek, a public web-based application designed to share next generation scRNA-Seq data and results. Support work provided for these applications included: systems design, front-end development, middleware development, database development, and maintenance.